Robotic-Inserted, Shape-Conforming Cochlear Implant Electrode Arrays

Project Summary/Abstract
During this Phase I effort, we seek to assess the viability of robotic-assisted, shape-conforming cochlear implant
(CI) electrode arrays as a new solution for achieving atraumatic cochlear implantation and optimal electrode
positioning at the same time. Lateral wall electrodes have historically been the preferred CI electrode option due
to the higher likelihood of achieving atraumatic insertion and preserving residual hearing. However, placing
electrodes closer to the modiolus of the cochlea can offer potential performance benefits, such as more focal
stimulation and reduced current spread due to a shorter distance between the electrode and the spiral ganglion
neuron target. Unfortunately, conventional perimodiolar electrodes suffer from higher rates of trauma and
electrode displacement, negatively affecting the preservation of residual hearing.
We are addressing this major challenge by utilizing a shape-memory polymer (SMP) as a dynamic element that
induces controlled self-curling of the CI electrode arrays during cochlear implantation assisted by slow,
consistent-speed robotic insertion. This approach enables non-contact insertion and gentle curling of the arrays
closer to the modiolar wall during the implantation process. By uniquely combining the innovative material and
surgical approaches, the proposed technology enables reliable cochlear implantation and optimal electrode
placement at the same time, which is difficult to achieve with the current clinical CIs.
Our effort encompasses establishing a computational model for the SMP-integrated CI arrays and evaluating
their insertion reconfiguration profiles in a model cochlea. We will rigorously validate our approach through
computational and experimental analyses including dynamic mechanical analysis and quantitative assessments
of the insertion profiles based on macroscopic and microscopic imaging.

Public health relevance
Project Narrative Cochlear implants (CIs) have been one of the most prevailing neural prostheses, yet a significant number of CI recipients still experience only poor to moderate speech understanding. Current CIs have trouble achieving simultaneous atraumatic insertion and effective placement of intracochlear electrodes, and we are tackling this problem with a novel solution employing a shape-memory polymer (SMP) as an integrated component for CI electrodes along with robotic-assisted insertion. This project will validate that the SMP-integrated CI electrodes assisted by robotic insertion will lead to more reliable cochlear implantation alongside favorable electrode placement.